Pittsburgh Center for Kidney Research

The critical role of the kidney in maintaining homeostatic balance, and the disorders of
homeostasis that accompany diseases of the kidney and the associated loss of kidney function
underscore the importance of this organ in human health. The Aims of our Pittsburgh Center for
Kidney Research are (i) to provide critical resources for investigators throughout the US to
advance studies of normal and abnormal kidney function and the cellular mechanisms that
contribute to these states, (ii) to expand the diversity of the kidney research workforce by
facilitating research efforts of early-stage investigators and established investigators who are
new to kidney research, (iii) to educate students and community members about kidney function
and disease through summer student enrichment program and a lay education program, and
(iv) to speed research progress through active collaborations with other Consortium members. A
central goal of our O'Brien Kidney National Resource Center is to provide investigators across
the US with expertise in both classical and novel physiological approaches to dissect kidney
function in normal and disease states. Our Cores will provide an integrated approach to address
kidney-specific questions across a broad range of physical resolutions, ranging from molecules
to whole animals using a variety of model systems amenable to genetic manipulation, and
complement these studies using cutting edge imaging approaches tailored for an investigator’s
specific needs. Our Resource Development Core will provide state-of-the-art imaging and
develop new imaging tools and techniques to accelerate kidney-focused research, and
complements our Biomedical Resource Cores that focus on Physiology and Model Systems. An
Administrative Core provides oversight of the Center, its Core facilities, and the summer student
enrichment and lay education programs. Our Center and Cores are led by a team of talented
investigators with diverse research interests who have strong, collaborative research programs
at the University of Pittsburgh and at the Icahn School of Medicine at Mount Sinai. Our Center is
designed to realize our goal of providing kidney investigators with the knowledge and cutting-
edge tools necessary to study normal and abnormal kidney function.

Public health relevance
The goals of the Pittsburgh Center for Kidney Research, a George M. O'Brien Kidney National Resource Center, are to provide critical resources for investigators throughout the US to advance studies of normal and abnormal kidney function and the cellular mechanisms that contribute to these states. To achieve these goals, the center supports an Administrative Core, two Biomedical Research Cores, a Resource Development Core, a Summer Educational Experience Program for undergraduate students and a Lay Education Program.